The role of endothelial derived Leucine-Rich Alpha-2-Glycoprotein 1 (LRG1) in the pathogenesis of COPD

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death worldwide and current
therapy only treats symptoms but cannot stop progression of this debilitating disease. COPD is defined as a
clinical syndrome characterized by respiratory symptoms, airflow limitation that is irreversible, and pulmonary
structure abnormalities (emphysema and/or airways disease). The key pathologic features of COPD lungs are
chronic inflammation, tissue destruction, and vascular abnormalities. Emerging data points to the centrality of
the lung microvasculature to the pathogenesis of COPD but little is known of how vascular damage leads to
progressive lung destruction. This proposal addresses the critical need to define the mechanism(s) of vascular
pathogenesis of COPD to provide a therapeutic path forward and to reduce the morbidity and mortality for millions
of patients with this disease. We have shown that in human COPD lung tissue loss of expression of key
endothelial markers, suggestive of vascular dysfunction, is profound and linked to disease severity. We also
found vascular dysfunction in a murine model of emphysema and showed that restoring the pulmonary vascular
niche with pulmonary capillary endothelial cell (PCEC) therapy ameliorated emphysema. These data support
the novel concept that the “pulmonary vascular niche” is critical to the integrity of the alveolar-capillary unit, but
these results are the first to show that re-establishing the pulmonary endothelial compartment can change the
course of the emphysematous state. In PCECs isolated from emphysematous lung, leucine-rich alpha-2-
glycoprotein-1 (Lrg1) was a top up-regulated gene. LRG1, is a secreted glycoprotein that binds to the TGF-𝜷
accessory receptor that in ECs distorts their signaling to cause aberrant blood vessels in several disease states.
In this proposal, we hypothesize that excessive levels of PCEC-derived LRG1 alters homeostatic functions of
PCECs leading to a dysregulated vascular niche whereby the development of emphysema ensues. Aim
determine
employing
exposed
excessive
3,
and
to
strategies
successful
Cornell
resources
1, will
the mechanism(s) by which PCEC LRG1 promotes he pathogenesis of emphysema in mice by
the use of genetically modified mice lacking Lrg1 in the adult endothelium. These mice will be
to the cigarette smoke and elastase induced models of emphysema. Aim 2, will define the impact of
levels of LRG1 on the alveolar-capillary network in human vascularized lung organoid models. Aim
will determine the extent to which perturbations of LRG1 signaling blocks the emphysema phenotype in murine
human model systems using a neutralizing antibody against LRG1. These studies will uncover mechanisms
promote normalization of the pulmonary vascular niche o allow alveolar repair and the development of novel
to treat COPD. This proposal plays a central role in a career development plan for becoming a
independent investigator focused on vascular dysfunctions in the pathogenesis of COPD. Weill
Medicine is an ideal environment in which to execute this training plan because of its rich scientific
and the strength of the track record of strong mentorship of early-stage investigators.
t
t

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death worldwide and current therapy only treats symptoms but cannot stop progression of this debilitating disease. We have found evidence that vascular dysfunction leads the development of the type of lung destruction that is found in COPD. In this proposal, we aim to uncover new therapies targeting the vascular impairments causing the disease state of COPD in the hopes of improving the lives of millions of patients.